National Center for Food Safety and Technology

PROJECT SUMMARY
The Institute for Food Safety and Health (IFSH) National Center for Food Safety and
Technology (NCFST) is a food safety and applied nutrition research consortium of the US Food
and Drug Administration's Center for Food Safety and Applied Nutrition (FDA/CFSAN), the
Illinois Institute of Technology (IIT), and the food industry. Since the establishment in 1988,
NCFST has successfully provided a unique collaborative neutral ground where scientists from
academia, government, and industry join forces and work together to address food safety issues
of national significance. These successes were achieved as a result of NCFST partnering with
industry, academia, and the FDA. NCFST is structured so that representatives of participating
organizations play a role in establishing policy and administrative procedures, as well as
identifying long- and short-term research programs that address FDA and industry strategic
needs. With this organizational structure, NCFST is uniquely positioned to build cooperative
food safety programs on a foundation of knowledge about current industrial trends in food
processing and packaging technologies, regulatory perspectives from public health
organizations, and fundamental scientific expertise from academia. The NCFST collaborative
research programs in food safety are coordinated through the Science Forum, with five research
platforms including Food Processing and Packaging, Food Microbiology, Food Chemistry and
Allergen, Proficiency Testing and Method Validation, and Nutrition. Research conducted at
NCFST addresses key food safety issues facing the country and supports the development of
safe food with health-promoting properties from farm to fork. This research forms a scientific
basis for policy decisions affecting food safety and public health. In addition, NCFST is the
coordinator of the Food Safety Preventive Controls Alliance (FSPCA) and the Sprouts Safety
Alliance (SSA), leveraging the expertise of academia, industry, and FDA for the purpose of
developing and delivering standardized curricula related to FDA Food Safety Modernization Act
(FSMA) requirements. These Alliances are key integral parts of the FDA's FSMA
implementation strategies.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Brackett, Robert E. PROJECT NARRATIVE Since 1988, NCFST has received support from the FDA under seven previously awarded cooperative agreements (53 FR 15736; 56 FR 46189; 59 FR 24703; 64 FR 39512; 69 FR 25405; and 74 FR 26408, U19FD005322). This five-year renewal award provides continued support to the collaborative research, education and outreach programs related to the safety of food processing technologies and processed foods, and further improves public health. 0925-0001 (Rev. 03/16) Page Continuation Format Page